FDA FERN Microbiological Cooperative Agreement CP (U18)-NC

NCDA&CS RFA-FD-15-019 North Carolina Department of Agriculture & Consumer Services Project Summary The North Carolina Department of Agriculture & Consumer Services (NCDA&CS), Food & Drug Protection Division (FDPD) Laboratory is pleased to have the opportunity to submit a proposal for continuation of our Food and Drug Administration (FDA) Food Emergency Response Network (FERN) Microbiological Cooperative Agreement. We are committed to completing the key project areas outlined in RFA-FD-15-019, including: ? analyses of FDA FERN samples; ? provision of surge testing capacity to FDA; ? utilization of standard methods and equipment platforms; ? participation in proficiency testing programs to confirm competency; ? participation in FDA and FERN sponsored training; and ? method development, validations and matrix extensions. The Laboratory has the infrastructure and personnel in place to accomplish all deliverables set forth by FERN and FDA in this Cooperative Agreement. Through current inspection and surveillance programs, threat agent and foodborne organism analyses, and extensive technical expertise, FDPD can provide added value to our federal partners. Page 1 of 1

Public health relevance
NCDA&CS RFA-FD-15-019 North Carolina Department of Agriculture & Consumer Services Project Narrative In the event of a large-scale outbreak or threat incident, Food and Drug Administration (FDA) laboratories may not have the capacity to accommodate all necessary testing. The availability of state laboratories with the same equipment and test method competency as the FDA laboratories is critical to sustaining a large event. The North Carolina Department of Agriculture & Consumer Services (NCDA&CS) Food & Drug Protection Division (FDPD) Microbiology Laboratory has the capability, capacity and competency to provide surge testing to support a local or national food safety or defense incident. The Microbiology Laboratory has a strong partnership with the Food Emergency Response Network (FERN), as a Cooperative Agreement Laboratory with both FDA and the Food Safety and Inspection Service (FSIS) for several years. We have provided method validation and matrix extension data to the National Program Office, supplied surge capacity testing when requested, completed surveillance assignments, and been a source of information and expertise to other laboratories within the network. We are an active participant in the FERN community and we will continue these partnerships through this FDA-funded Cooperative Agreement. The FDPD is committed to supporting food safety and defense locally and nationally. We have been involved with and support multiple local and national activities and initiatives. Examples of these initiatives are listed below. • Since early 2011, we have been highly involved with FDA and the Partnership for Food Protection initiatives, having representatives on Laboratory subcommittees for the Regulatory Annex, Proficiency Testing, Method Selection, and Accreditation. • NC has a very active Food Safety and Defense Task Force comprised of regulatory agencies (NCDA&CS, NC Department of Health and Human Services Division of Public Health, and FDA), industry, retail, and academia. The FDPD Management, Food Program and Laboratories participate in bimonthly state-wide meetings and serve on various committees to develop and implement initiatives for food safety and defense. Laboratory staff are available as subject matter experts. • The FDPD Laboratory is a member of the Association of Public Health Laboratories (APHL) and participates on quarterly conference calls with APHL and other state agricultural lab representatives. Conference call agendas include sharing ideas and issues for food safety and defense testing. • The Commissioner of the NCDA&CS, Steve Troxler, has served as the President of the National Association of State Departments of Agriculture (NASDA) and Chair of the Food Regulation and Nutrition Committee, which includes a focus on food safety. Commissioner Troxler has been an avid supporter of food safety and defense in NC, sponsoring an annual Commissioner's Food Safety Conference for 10 years. The NCDA&CS FDPD Microbiology Laboratory is committed to working with local, state and federal partners in food safety and defense. Page 1 of 1